Generation of Parkinson-derived human glial progenitor cells for dopaminergic neuronal conversion

Project Summary/Abstract
Parkinson’s disease (PD) is classically characterized by the progressive loss of dopaminergic neurons leading
to the emergence of debilitating motor, and non-motor symptoms. As the CNS does not replace neurons lost
to injury or disease, a primary focus in developing therapeutic strategies for PD has centered around the idea
of grafting replacement dopaminergic neurons. Early neurosurgical approaches using fetal ventral midbrain
allografts produced some mixed, but encouraging results. As fetal donor tissue presents challenges in regard
to sourcing and ethics, variability, immunogenicity, and cost, recent efforts have focused on the prospect of
using induced pluripotent cells driven to a dopaminergic neuronal fate. The advantages of this precision
medicine approach, where the patient’s own cells are engineered into the replacement neurons, is offset by the
effort and cost to produce and differentiate cells under cGMP conditions, with the ultimate delivery requiring
invasive neurosurgery. We propose to bypass the need to generate dopaminergic neurons exogenously, by
using an alternative approach where glial progenitor cells already present in the Parkinson’s patient’s brain
could be directly reprogrammed to become dopaminergic neurons. In exploring this approach, access to adult
human glial progenitor cells from non-affected or PD-patients is a limitation and reprogramming of adult human
glial progenitor cells into dopaminergic neurons has not yet been reported. We have successfully targeted rat
oligodendrocyte progenitor cells (OPCs) in vivo to reprogram them into a neuronal lineage. With this
Exploratory/Developmental R21 mechanism award, we propose to lineage reprogram human OPCs into
dopaminergic neurons to ultimately replace neurons lost in PD. In Aim 1, we will test the hypothesis that PD-
derived fibroblasts directly reprogrammed into human OPCs without passing through a pluripotent state retain
their epigenetic signature and can model the human OPCs we eventually intend to target for neuronal
replacement in the PD brain. Aim 2 will test the hypothesis that temporal sequential reprogramming can direct
adult-derived human OPCs from non-affected and PD-patients to become dopamine neurons. These in vitro
studies, determining the timing and sequence of lineage specification instructions to generate dopaminergic
neurons, will lay the necessary foundation for the future step using direct in vivo delivery to model a
reprogramming neuronal replacement therapy for PD. This project also has implications for testing the
capacity to drive the generated human OPCs to complete differentiation as oligodendrocytes and to then
address myelination deficiencies in Parkinson’s disease.

Public health relevance
Project Narrative Replacement of dopaminergic neurons to treat Parkinson’s disease is a long-standing goal that may be achieved by recruiting stem cells to become dopaminergic neurons. As an alternative to generating dopaminergic neurons from iPSCs, we propose to generate human glial progenitor cells and directly reprogram them into dopaminergic neurons. As such glial progenitor cells are already present in the brains of Parkinson’s patients, this project will establish a model for eventual in vivo reprogramming to generate dopaminergic neurons in situ, without the need to graft exogenous cells as a neuronal replacement therapy for Parkinson’s disease.